Climate, Population Health, and Well-being over Time

? DESCRIPTION (provided by applicant): This project investigates how short- to medium-term climate variability affects population well-being and migration across a wide spectrum of development and urbanization. The project focuses on China over a period of rapid transformation (1989-2014). Social data will be derived from two large-sample longitudinal household surveys that have measured health, economic status and population mobility across China during this time period. These social data will be linked to high-resolution gridded climate data in order to measure population exposure to precipitation and temperature over 1-24 month time scales. Multivariate regression models will then be used to measure the effects of climate variability on well-being and migration while accounting for nonlinear relationships and a variety of potential spatial and temporal confounders. These analyses will be extended to reveal which populations are most vulnerable to these effects, and whether these effects have increased or decreased over time and with urbanization. This research will represent an important advance in the measurement of climate vulnerability, and will contribute directly to the global conversation about vulnerability to future climate change.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project investigates how short- to medium-term climate variability affects health, economic status, and migration across a spectrum of development and urbanization, focusing on China from 1989 to 2014. Social and climate data will be linked and analyzed in order to measure how variations in precipitation and temperature affect population well-being and mobility, as well as how these relationships vary across population groups and over time.